Neuron-Glial Interactions in Basal Ganglia Circuitry

Recent studies show that striatal astrocytes can affect and be affected by the ambient dopamine in the striatum.
Electrophysiological studies show that striosomes also have reciprocal effects on dopamine, with powerful direct
projections onto the dopamine-containing neurons in the substantia nigra pars compacta (SNpc) such that they
can shut down dopamine neuron activity and then evoke a rebound excitation, likely playing a critical role in state
transitions of behavior. In accordance with these data, we have found preliminary evidence that the striatal
astrocyte activity and striatal dopamine activity are correlated tightly with each other while mice perform decision-
making tasks. Large transients of astrocytic activity, with timescales on the order of seconds, occur around the
transition of behavioral states from task engagement to non-engagement or vice versa. Prompted by these
findings, we propose here to investigate whether striatal astrocytes, in cooperation with the striosomes of the
striatum, exert a facilitative role in state transitions by modulating dopamine signals in the striato-nigro-striatal
loop. We will ask whether astrocyte activity causally affects learning, state transitions of behavior, from
engagement to non-engagement, from strategy shifting to judging cost-benefit options, and whether astrocytes
track changes associated with striatal dopamine release and activities of striatal projection neurons in millisecond
and second timescales. We propose here to seek the possible role of striatal astrocytes in transitions of
behavioral states via modulation of the dopamine signals transmitted along the striato-nigro-striatal loops. The
striatum is one of the core brain regions to implement reinforcement learning and make transitions from an
exploratory/learning phase to an exploitation/habitual phase of behavior. The striosomes, which are
neurochemically specialized striatal compartments, have been shown to be specifically involved in the
development of habitual behavior and recently in switches between unengaged and engaged states of behavior.
This then poses the question “how can striosomes make a transition in a behavioral state?”. We will also
approach the issues of whether these astrocytic modulations are exerted locally in the striatum as well as, our
main focus, through the striato-nigro-striatal loop, by modulating activities of strioSPNs and dopamine-containing
neurons in SNpc. We will, for this work, combine many advanced state-of-the-art methods including
optogenetics, chemogenetics, intersectional viral and transgenic mouse line approaches, novel enhancer-based
cell-targeting methods combined with photometric imaging and the use of chemosensors for registering
dopamine release. This work is novel and at the front edge of new concepts of neuromodulatory mechanisms in
controlling cognitive processing in the brain. Thus, the proposed work is crucial for and aligns with the goals
outlined in the Notice of Special Interest (NIMH) regarding neuro-glial interactions by directly addressing
profound issues about key dopamine-related astrocyte involvement in functions affected by mental health
disorders.

Public health relevance
As the environment is stable yet volatile at times, we flip our cognitive strategy if the previous rules are no longer applicable or need to be updated for the current environment. The disrupted balance of behavioral states can lead to neuropsychiatric symptoms including depression, as seen in Parkinson’s disease, implicating the dopamine system to be a key. Here, based on our preliminary data, we seek the possibility that striatal astrocytes, beyond their homeostatically supportive roles, modulate the dopamine system through the striato-nigro-striatal loop, to aid transitions of behavioral states.